Combining Separation, Digestion, and Ionization on a Mass Spectrometry Cartridge to Enable Biomedical Research on Proteoforms

Project Summary
Each protein consists of numerous different molecular entities, termed proteoforms. These different forms arise
from post-translation modifications, alternative, and genetic mutations among others. Proteoforms can have
different biological function, alternations can cause disease, and they can serve as highly specific biomarkers.
Proteoform analysis is, therefore, an important frontier in biomedical research. Progress is slow, however,
because current technology is inadequate. On one hand, better high-performance protein measurement tools
are needed for some applications to reach ever deeper into the proteoform. On the other hand, faster and simpler
tools are needed for other applications to scale up proteoform research and increase participation in the field by
scientists who are not protein mass spectrometry (MS) specialists. To that end, this proposal aims to develop
self-contained analytical devices (‘cartridges’) that combines all of the components necessary to analyze both
intact proteins and proteolytic peptides. The cartridge will include an antibody-based preconcentration system,
an immobilized enzyme to perform protein digestion if desired, and a built-in substrate to perform protein
ionization by electrospray. The cartridge will allow the entirety of the protein analysis workflow to occur
automatically on a single device that can be directly coupled to the mass spectrometer. All of these processes will
be designed to work without external pumping or other complex systems for sample handling. In Aim 1, a device
will be developed that combines affinity-based protein purification with a porous material to perform
electrospray ionization (substrate-supported electrospray ionization or ssESI). Proteoforms captured by the
affinity material will be eluted onto the ionization material for immediate detection using top-down mass
spectrometry. In Aim 2, an enzymatic digestion step will be integrated into the analysis cartridge to enable
detection of proteoforms at the peptide level. While digestion of proteoforms has disadvantages, it does enable
more sensitive detection and better sequencing by tandem mass spectrometry. In Aim 3, electrophoretic
methods will be developed to separate and stack proteoforms on the ionization substrate. The electrophoretic
manipulations will be designed to occur in minutes. Separations will be mainly designed to reduce or eliminate
ion suppression, while stacking will be done to improve detection limits.

Public health relevance
Project Narrative Proteoforms, the diverse molecular entities that comprise a protein, can have myriad biological functions and roles in disease. The most powerful method for proteoform measurement is mass spectrometry, but proteoform measurement using this instrument tends to be slow and difficult. We aim to develop technologies to enable rapid and simpler proteoform measurement by mass spectrometry for the purpose of enabling more biomedical research into proteoform function in biology and human disease.